Molecular Analysis of Developmental Brain Disorders Associated with Synaptic Pathology

ABSTRACT
The molecular mechanisms of synaptopathy that arise downstream of the large number of gene conferring risk
for these disorders remains unclear. Particularly, how different risk genes may segregate into common
molecular mechanisms has been challenging to identify. Likewise, how genetic missense variants result in
pathology remains an enigma. These gaps in knowledge pose a significant barrier to the field and limit our
ability to envision stratagies to ameliorate pathogenesis. In this project, we will develop and utilize innovative
proteomic, scRNA-seq, and genome engineering approaches to solve these problems at larger scales than
previously possible in animals. We anticipate these data will provide a new and unparalleled molecular
framework for ASD and related disorders as well as future studies on new targets to beneficially modulate
behavior.

Public health relevance
RELEVANCE The goal of this grant is to uncover the molecular mechanisms that mediate pathogenesis downstream of a large number of genes strongly implicated in Autism Spectrum Disorders (ASD). A leading hypothesis in the field is that ASD genes converge on common pathways, however the molecular details of this remains unknown. As such, a better understanding of the fundamental mechanisms shared between ASD genes, and how pathogenic variants alter these pathways could be expected to paradigm shifting. We anticipate this work will yield novel insights into how human genetic mutations are associated with ASD and whether there are common downstream perturbations between different ASD genes.